FASEB SRC: The Lung Epithelium Conference: In Health and Disease

Project Summary
The 2022 FASEB Summer Research Conference, "The Lung Epithelium in Health and Disease", is the 11th
biannual conference in this area, bringing together developmental, cell and molecular biologists, geneticists,
physiologists, clinicians and translational researchers with a primary interest in lung epithelial biology. The topics
selected represent the cutting-edge of lung research and the program is planned to disseminate new findings
with translational potential to accelerate progress toward novel therapies for lung disease. Topics include (1)
molecular mechanisms of lung epithelial development, repair/regeneration, and plasticity (2) common and unique
pathways of intra-epithelial communications in lung physiology and diseases, (3) interactions between lung
epithelium and distinct immune cells, including in the context of COVID-19 infection (4) cutting-edge technologies
including single-cell analysis approaches and ex-vivo models for investigating lung epithelial biology . In addition
to the unique collection of research topics, this meeting provides a platform for new speakers, early stage
investigators, and trainees. Twenty-three of 33 speakers (70%) have not spoken at this conference in the last
four years, and sixteen of the 40 speakers/session chairs (40%) are women. Sixteen short-talk sessions are
designated for trainees or new investigators. Specific efforts are being made to encourage participation by
underrepresent minorities in the field. In addition to talks, there are 3 poster sessions and 4 “Meet-the-Experts”
sessions to facilitate scientific and social interactions between all participants. By bringing the best of the lung
epithelium research community together, the overall goal of this conference is to push the field forward towards
innovative directions for basic research and novel therapeutics for important lung diseases, including asthma,
chronic obstructive pulmonary disease, pulmonary fibrosis, and bronchopulmonary dysplasia.

Public health relevance
Project Narrative The 2022 FASEB Summer Research Conference, “The Lung Epithelium in Health and Disease,” brings together basic scientists, translational researchers and clinician investigators to discuss state-of-the-art approaches to understand the molecular mechanisms which underlie a broad range of respiratory diseases such as asthma, bronchopulmonary dysplasia, chronic obstructive pulmonary disease, idiopathic pulmonary fibrosis, COVID-19, and others. The objectives of the conference are to 1) stimulate meaningful discussion, 2) facilitate collaboration, 3) establish new research directions and priorities, and 4) serve as a major forum for early stage investigators and trainees to present their work, facilitating development of the “next generation” of lung epithelial biologists. By linking the pathobiology of these disorders to normal lung development and lung cell differentiation, central themes will be identified to provide a mechanistic understanding of these diseases, and will accelerate progress toward the development of novel therapeutic approaches for a variety of lung diseases.